Sperm Ca2+ Signaling and Energy Pathways in basic science and ART

Project Summary Abstract
Infertility and subfertility are critical health problems affecting about 9 % of couples worldwide. Since the first
successful “Test-Tube” baby in 1978, over 5 million babies were born using Assisted Reproductive Technology
(ART). ART includes such techniques as in vitro fertilization (IVF), intrauterine insemination (IUI),
intracytoplasmic sperm injection (ICSI) and embryo transfer techniques. ART is used in humans, and in
animals of economic relevance. In humans alone, IVF and ICSI are used ~ 800,000 times per year. In all
species, the limiting factor for successful pregnancies to occur is obtaining good quality preimplantation
embryos which have a direct influence in implantation and pregnancy rates. Capacitation involves crosstalk
between metabolic and signaling pathways. We showed that a short incubation with the Ca2+ ionophore
A23187[7] can induce in vitro fertilizing capacity in sperm from sterile knock-out (KO) genetic models. We
hypothesized that, at least, in part, A23187’s effects were due to changes in metabolism. When sperm
metabolism was changed using starvation and rescue protocols, we observed that intracellular Ca2+ was
elevated. This proposal has basic and applied goals. The basic science objective is to understand the
molecular basis of these methods with particular emphasis on the crosstalk between calcium and metabolic
pathways. At the translational level, our goal is to use novel sperm incubation conditions to improve ART. This
administrative supplement to support Dr. William David Weber’s career development has new approaches and
it is synergic to the parent grant HD38082. The application also focuses in a mentoring plan as well as in
enhancing Dr. Weber’s research skills to become an independent researcher.

Public health relevance
We have discovered two new sperm incubation methods based on the regulation of intracellular calcium and metabolic pathways; these methods improve sperm functional parameters which increase the percentage eggs that can be fertilized in vitro and also improve early embryo development and pregnancy rates. This administrative supplement is to support research of Dr. David Weber, who is a first generation graduate, on research synergic to the parent grant HD38082 with the goal of enhancing Dr. Weber’s scientific skills and provide him with a career path to become independent.